The development and function of aging-associate innate lymphoid cells in the choroid plexus

Project Summary/Abstract
The goal of this project is to understand the development and function of aging-associate lymphocytes. This
proposal focuses on group 2 innate lymphoid cells (ILC2) that accumulate in the choroid plexus (CP) with
aging. Aging is a complicated process associated with profound changes in the immune system, characterized
by both a deterioration of adaptive immune function (immunosenescence) and also increased inflammation
(inflammaging). Suprisingly, some immune cell subsets with anti-inflammatory and reparative function also
accumulate with aging, which might represent a protective negative feedback mechanism to counter
inflammaging. Our recent work discovers that group-2 innate lymphoid cells (ILC2), a type of tissue-resident
innate lymphocytes, accumulate in the CP of aged mice and humans. The goal of this proposal is to
understand the development and function of these aging-associated innate lymphoid cells in the CP. We will
use lineage tracking mice, precursor homing assay, and adoptive transfer to examine the developmental
origins of these cells and to explore the factors that lead to their accumulation with aging. We will use ILC2
deficient and ILC2 inducible-deletion mice to examine the specific role of these cells in physiological aging.
Finally, we will test whether enhancing ILC2 function can alleviate neuroinflammation and cognitive impairment
in aged mice with Alzheimer’s disease associated pathologies. We expect that the data generated will provide
significant insights into the mechanisms of immune cell aging, and will inform strategies to combat geriatric
diseases.

Public health relevance
Project Narrative This project aims at understanding the development and function of innate lymphoid cells in the choroid plexus. Our work will provide novel insights into the mechanisms of immune cell aging, and may also inform strategies to combat geriatric diseases such as Alzheimer’s disease.